Integrative Yoga and Mindful Self-Compassion to Reduce Distress in Women Survivors of Interpersonal Violence

PROJECT ABSTRACT
The overall objective of this Mentored Research Scientist Career Development Award is to support Dr. Tosca
Braun’s transition to an independent investigator with a focus on using community-engaged approaches to
develop and disseminate community-engaged mindfulness-based interventions to advance health in vulnerable
and minority populations. Interpersonal violence is commonly experienced among Black/African American (AA;
44%), Hispanic/Latino/a/x (34%), and non-Hispanic/Latino/a/x White women (37%) in the US, as well as
stigmatization related to IV and other attributes (e.g., race/ethnicity, weight). Violence and stigma both drive
“downstream” poor behavioral and physical health. Stigma sequelae – distress in response to stigma, anticipated
(fear of) stigma, internalized stigma – independently foster shame and affect dysregulation, thus magnifying
distress and consequent health impacts. These interpersonal violence (IV) sequelae can be alleviated by
reducing distress, yet culturally sensitive transdiagnostic approaches to reduce survivor distress across ethno-
racial populations are rare. We propose to use community-engaged research to develop a complementary
medicine program that integrates adapted Mindful Self-Compassion (MSC) training with Trauma-Informed Yoga
(TIY) to improve stigma sequelae and reduce distress in ethno-racially diverse survivors: Integrated TIY and
MSC (I-YMSC). MSC targets stigma-related problems (affect dysregulation, shame) and improves distress in
the long-term, yet can temporarily increase short-term distress. TIY reduces short-term distress and promotes
physiological-autonomic regulation. Dr. Braun’s program evaluation data suggests adapting MSC to explicitly
address cultural factors and intersectional stigma and integrating this approach with TIY is strongly warranted
and has potential to ameliorate health inequities experienced by ethno-racially diverse IV survivors. Further,
training community yoga instructor survivors to teach I-YMSC represents an additional level of engagement with
our stigmatized target population that is unusual in mindfulness research. In this K23 proposal, Black/AA,
Hispanic/Latino/a/x, and White survivors will be equally represented across all project phases (33% each), with
results considered both across participants and within each subgroup. Specific aims include: (1) (1.1) develop I-
YMSC using community-engaged research with women IV survivor stakeholder partners, (1.2) pre-pilot the
intervention in an open pilot trial to further refine the intervention, (1.3) develop a community-engaged teacher
training, and (2) (2.1) conduct a 2-armed test of the behavioral intervention compared to a health education
control to assess the feasibility and acceptability of the I-YMSC intervention, and (2.2) pilot the teacher training.
The essential hands-on learning and mentored training in this grant will support Dr. Braun in establishing her
program of research as an independent investigator in community-engaged mind-body research working with
vulnerable and minority populations, including women survivors of violence. Findings may also have applicability
to promoting health resiliency and restoration in other marginalized populations who experience health inequities.

Public health relevance
PROJECT NARRATIVE Women interpersonal violence (IV) survivors are at risk for experiencing stigma which can compound IV-related distress and “downstream” adverse health outcomes, and intersectionalities of vulnerable identities amplify health risk. The proposed community-engaged integrated trauma-informed yoga and adapted mindful self- compassion (I-YMSC) intervention offers a complementary and integrative approach (CIA) for reducing distress as a mechanism for improving psychological, behavioral, and physical health in ethno-racially diverse women. Short-term, this research will contribute to our understanding of the feasibility and acceptability of a novel, multicomponent CIA to reduce distress among diverse IV survivors; long-term, this research has potential to increase our knowledge of approaches to promote health equity in other marginalized groups.